Core A - Administrative Core

ABSTRACT: Administrative Core (Core A)
The purpose of the Administrative Core (Core A) is to provide centralized administrative management, financial
control services, clerical and materials management, and data processing support to all projects and cores. This
Core will also ensure seamless interactions and communication between all participants by providing necessary
support for the organization and conduct of meetings as well as regular communications with the NIH and strive
to promote the highest level of integration between the program’s components. The Core A will organize an
annual retreat where the members of the Scientific Advisory Board will meet with Program leaders to provide the
status of the progress of the grant. As the admin PI of this program Grant and Lead of the Administrative Core,
Dr. Kristy K. Brock, in consultation with the Steering Committee and the Scientific Advisory Board, will be
responsible for providing overall direction to the quality, integration, scientific progress, and administrative
operations of the program. Dr. Brock will be responsible for deciding policy matters relating to research priorities
and problems concerning projects, cores, resources, and the overall program management. By design, this core
will provide investigators clear lines of scientific and administrative communication, aid in the prioritization of
resources as they relate to the integration and progression of the proposed projects and shared resource cores
and facilitate resolution of any problems that affect team members.

Public health relevance
NARRATIVE: Administrative Core (Core A) The purpose of the Administrative Core (Core A) is to provide centralized administrative management, financial control services, clerical and materials management, and data processing for all projects and cores. This Core will strive to promote the highest level of integration between the program’s components and ensure seamless interactions by facilitating internal and external communication and coordination between all participants. It will provide support for the organization and hosting of the Advisory Board meetings.